Tsepamo Next Generation: Optimizing HIV Treatment and Prevention Strategies for Pregnant Women in Botswana

Project Summary/Abstract
This study will address two critical questions related to pregnant women living with HIV and their infants: 1) can
two-drug antiretroviral treatment (ART) be used safely and effectively among pregnant women living with HIV?
and 2) how can we most efficiently identify those at risk and prevent HIV infection among pregnant women?
For Aim 1, there is a need to research two-drug ART with dolutegravir/lamivudine (DTG/3TC) in pregnancy,
particularly in resource-limited settings. Botswana's imminent transition to DTG/3TC for all adults presents a
unique opportunity to study its effects on maternal weight gain, viral suppression in pregnancy, adverse birth
outcomes, and vertical transmission. This aim can be efficiently accomplished within the existing Tsepamo
Study surveillance system by creating an emulated clinical trial and by utilizing over 2,400 mother–child pairs
with targeted specimen collection. For Aim 2, the Tsepamo surveillance infrastructure also provides an ideal
mechanism to identify recently infected pregnant women. We will determine the drivers of incident HIV
infections in this population by 1) performing phylogenetic analyses linked to nationwide cluster surveillance
performed at the Botswana Harvard Health Partnership (BHP), including evaluation of transmitted drug
resistance, and 2) using in-depth interviews and questionnaires to understand current demographic and
behavioral risk factors. Additionally, we will assess whether recent seroconverters would have been good
candidates for / accepting of long-acting PrEP. Ultimately, the findings of this study will inform international
guidelines, ensuring safer ART options for pregnant women that harmonize with adult treatment guidelines and
inform upcoming strategies to roll out long-acting PrEP in high-risk women.

Public health relevance
Project Narrative The Tsepamo Study has provided critical data for pregnancy outcomes in Botswana since 2014, and has the ability to expand into key new research areas: 1) the safety and efficacy of two-drug ART, and 2) drivers and clustering of new HIV transmissions in young women. With Botswana's recent adoption of 2-drug ART regimens for stable HIV-infected adults, we have the opportunity to perform a comprehensive evaluation of 2-drug ART in pregnancy by emulating a randomized clinical trial comparing DTG/3TC and DTG/TDF/3TC. Additionally, the Tsepamo surveillance infrastructure can identify and analyze recent HIV seroconversions to study transmission clusters, risk factors, and the acceptability of long-acting pre-exposure prophylaxis.